Prevention of Attachment Insecurity, Physiological Dysregulation, and Child Behavior Problems

A growing body of scientific evidence demonstrates that secure attachment and sensitive caregiving are
important sources of resilience for children living in stressful environments (e.g., Graham & Easterbrooks,
2000), contributing to children’s mental and physical health (Shonkoff, 2016). Conversely, research indicates
that insecure attachment is an important risk factor for the development of both childhood behavior problems
and physiological dysregulation (e.g., Luijk et al., 2010; see Fearon et al., 2010, and Groh et al., 2012, for meta-
analytic findings). Thus, efforts to prevent insecure attachment are crucial for children’s healthy development.
Although a few promising approaches to preventing insecure attachment, physiological dysregulation, and
childhood behavior problems have emerged (see Berlin et al., 2016), none has achieved widespread
implementation. What is urgently needed is evaluation of a comprehensive theory- and research-based
intervention protocol that can be widely implemented among families whose children are at elevated risk for
developing or maintaining insecure attachments, physiological dysregulation, and behavior problems.
The goal of the proposed study is to conduct an RCT of the Circle of Security – Parenting (COS-P)
intervention within Early Head Start (EHS) programs, in light of evidence that EHS children and families are
characterized by factors (e.g., low income, parental depression, exposure to violence/trauma; USDHHS,
2006a) that leave them at increased risk for insecure attachment and behavior problems. The project
addresses the NICHD CDBB priority of promoting psychosocial adjustment for at-risk children and of
understanding contributors to positive outcomes that can occur despite high-risk environments. Moreover,
the project addresses a critical barrier to progress in the attempt to reduce the risk of negative outcomes among
at-risk children by testing the efficacy of an intervention that was designed in collaboration with families and
staff from the real-world contexts in which it will be implemented. Principal aims are to examine whether the
addition of this brief attachment-based intervention to regular EHS services will (1) reduce child insecure
attachment, physiological dysregulation, and behavior problems; and (2) promote sensitive parental responses
to child distress. Additional aims are (3) to examine potential moderators of intervention effectiveness and (4)
to test whether changes in parental response to child distress act as a mechanism of positive change.
We have chosen HS/EHS as a strong service delivery mechanism because it is a widely available resource
in many communities, with an infrastructure and a commitment to the mental health of children. The HS/EHS
program has shown positive outcomes in some areas, yet evidence of reducing the risk of insecure attachment
is lacking (Spieker et al., 2005). The approach we take is noteworthy in that we consider the broader public
health context in which our attachment-oriented prevention protocol can be widely implemented.
The RCT includes 249 parent-child dyads from the Harrisburg, PA and Lehigh Valley, PA EHS programs.

Public health relevance
Growing evidence demonstrates that secure attachment in childhood predicts children’s healthy social, biological, and behavioral functioning, whereas insecure attachment predicts behavior problems and physiological dysregulation; thus, efforts to foster secure attachment are crucial for promoting the healthy development of children and families. This proposal describes a randomized controlled trial (RCT) of an innovative intervention program that can be widely implemented designed to foster children’s secure attachment, promote healthy physiological regulation, and reduce the risk for behavior problems: The Circle of Security – Parenting intervention. To this end, we will conduct an RCT with 249 parent-child dyads enrolled in two diverse Early Head Start programs.